Function Core - Core C

Michigan Integrative Musculoskeletal Health Core Center – Core C
Project Summary
Discovery of new targets and treatments for musculoskeletal diseases requires a deep understanding of the
basic biology of musculoskeletal development and function, rigorous research into the fundamental mechanisms
of disease pathogenesis, and robust testing of therapeutic targets and therapies aimed at improving disease
outcome. Research using animal models is a cornerstone of these efforts enabling the study of organ and
integrative organism function, the impact of environment, age, sex, and genetics on disease, and testing
therapies and outcomes with disease-relevant measures. The ability to study musculoskeletal phenotypes
across a wide-ranging scale of animal models requires considerable expertise and highly specialized training in
physiology, biophysics, and engineering, as well as access to costly, high-resolution, state-of-the-art equipment.
While occasionally the expertise and equipment for single approaches can be developed in a single laboratory,
developing these approaches can be cost prohibitive, redundant, and can lead to proliferation of non-uniform
techniques across the field. Rigorous and reproducible basic and preclinical research also requires robust
experimental planning that can span multi-modal testing platforms from cellular and organ level function to in
vivo physiology testing, in order to provide a fully comprehensive measure of phenotype or disease pathology.
In cross-disciplinary research, innovation often arises from collaborations that extend beyond the limits of
expertise in individual investigator laboratories alone. The overall long-term goal of the Function Core (Core C)
of the Michigan Integrative Musculoskeletal Health Center (MiMHC) is to provide state-of-the-art animal and
organ level phenotyping resources at the University of Michigan that can be used by the entire musculoskeletal
research community, regardless of individual expertise. The Core brings together the leadership and technical
experts in the physiology and biomechanics of the musculoskeletal system to provide fully staffed, specialized
laboratory approaches to musculoskeletal biology including whole animal in vivo phenotyping and surgical
models of musculoskeletal disease, and state-of-the-art measurements in bone mechanics, muscle function and
mechanics, tendon mechanics, and neuromuscular function. Further emphasis on training and sharing of new
technologies, standardization, and collaboration will expand the impact of Core C for our users and the broader
musculoskeletal research community.